Impact of HIV and Cannabis Use on Executive Brain Function and Inflammation

Project Summary/Abstract
While health outcomes for people with HIV (PWH) have greatly improved due to antiretroviral therapies,
executive dysfunction continues to impact up to an estimated 50% of PWH, highlighting a pressing need for
continued research in this area. Cannabis use is prevalent in this population largely for relief from peripheral HIV-
related symptoms such as nausea. Cannabis may also exert neuroprotective effects for PWH due to its
modulation of inflammation via the endocannabinoid system. Since systemic inflammation of the central nervous
system has been associated with cognitive declines among PWH, it is important to explore this potential pathway
of decreasing neuroinflammation. Recent work has attributed the use of cannabis among PWH with normalized
oscillatory brain activity in frontoparietal brain regions, which are necessary for executive functioning. However,
the literature is limited regarding the intersection of cannabis, neuroinflammation, and executive functioning as
indexed by both neuropsychological assessment and brain activation. Given the prevalence of cognitive
impairment among PWH, it is critical to characterize how the commonly used substance cannabis modulates
neuroinflammation and executive function abilities.
The proposed fellowship seeks to partially address this gap by utilizing the excellent spatial and temporal
precision of magnetoencephalography (MEG) in conjunction with neuropsychological assessment and plasma
inflammation levels. Briefly, adult PWH using and not using cannabis will be recruited in addition to
demographically matched samples of using and non-using healthy controls (four total groups). Participants will
undergo a blood draw for inflammatory biomarker testing, two NIH Cognitive Battery assessments for executive
function, and complete two executive function tasks during MEG. The inflammatory biomarkers will be combined
into one neuroinflammation index score via factor analysis and accuracy outcomes of the battery assessments
will be standardized for comparison. The MEG data will be transformed into the time-frequency domain and
imaged using a beamformer. The resulting dynamic functional maps will be utilized to examine spectrally specific
brain responses that are supportive of executive functioning, i.e. regions of the frontoparietal network. Aim 1 will
compare neuroinflammatory index scores between groups to examine the effect of cannabis on HIV-related
inflammation. Aim 2 will determine the impact of cannabis use on executive function assessment performance
and frontoparietal activation. To accomplish this, we will take advantage of the latest MEG and source
reconstruction techniques, neural oscillatory analysis methods, and cognitive assessments to examine the
influence of serostatus and cannabis usage on the neurophysiological bases of executive function. Aim 3 will
explore the differential relationships between frontoparietal oscillatory activity supporting executive function and
neuroinflammation among cannabis using and non-using PWH. In sum, this research will help elucidate the
potential of cannabis to mitigate neuroinflammation and executive dysfunction among PWH.

Public health relevance
Project Narrative Continued inflammation of the brain that many people with HIV experience despite viral suppression is a major contributor to HIV-related cognitive dysfunction. Cannabis, a commonly used substance by this population, may mitigate this cognitive decline through its anti-inflammatory effects, though the intersection of cannabis, neuroinflammation, and executive function is an understudied area of HIV research. The proposed work aims to address this gap through the training of a rising cognitive neuroscientist who will utilize state-of-the-art imaging technology and neuroinflammatory indexing to characterize the impact of cannabis use on HIV-related central nervous system inflammation and executive function performance and underlying neural activity among adults with HIV.